Scaling Up Research Ethics and Research Integrity (SURER) Project

Scaling Up Research Ethics and Research Integrity (SURER) Project
Project summary
Previous studies show that there is a need to build capacity for mentored Responsible Conduct of
Research (RCR), research/scientific integrity (RSI), Conflict of Interest (CoI), Diversity, Equity and Inclusion
(DEI), Safe Working Environment and Sexual Harassment training in Nigeria. Therefore, collaborators from the
University of Maryland School of Medicine, Center for Bioethics and Research, and the University of Ibadan,
Nigeria who have an established record of building bioethics capacity in Nigeria collaborated to develop a locally
contextual training program which is linked with local experiences, examples, resources and mentors to be
relevant and applicable to researchers' experiences.
In this new application, we engage our successful training resources, technologies, and models to build
institutional resources and infrastructure for RCR, RSI, CoI, DEI, Safe Working Environment and Sexual
Harassment in sixteen Nigerian universities. We advocate, build public and professional awareness, implement
training and innovative e-mentoring on RCR and RSI training, Safe Working Environment (SWE) and Sexual
Harassment for researchers in Nigeria. We work with our trainees to build repository of case studies, case
scenarios, and examples of RCR, RSI, CoI, DEI, Safe Working Environment and Sexual Harassment from the
local environment and incorporate these in our training programs. We evaluate the experiences and expectations
of our trainees and use these to create a Learning Educational Program (LEP) with regular adjustments and
updates to our curriculum contents and training examples.

Public health relevance
Scaling Up Research Ethics and Research Integrity (SURER) Project Project narrative With increasing number and scope of research projects, the University of Maryland School of Medicine, Center for Bioethics and Research and University of Ibadan, Nigeria identified need to build capacity for mentored Responsible Conduct of Research (RCR), research/scientific integrity (RSI), Conflict of Interest (CoI), Diversity, Equity, and Inclusion (DEI), Safe Working Environment and Sexual Harassment training to strengthen research environment in Nigeria. We engage our successful training resources, technologies, and models to create new institutional resources and infrastructure, conduct advocacy, build public and professional awareness, implement training and innovative e-mentoring for RCR, RSI, CoI, DEI, Safe Working Environment and Sexual Harassment in sixteen Nigerian universities. We use the experiences and expectations of our trainees and use these to create a Learning Educational Program (LEP) with regular adjustments and updates to our curriculum contents and training examples.